Myeloid Cells: Regulation and Inflammation

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Myeloid Cells: Regulation and Inflammation, organized by Vincenzo Cerundolo, Gwendalyn J. Randolph and David M. Mosser. The meeting will be held in Keystone, Colorado from February 19-24, 2013. Recent results have shown that during inflammatory processes, myeloid cells exhibit extensive plasticity of their phenotype in response to numerous stimuli. This characteristic directly affects lymphocyte polarization and activity and is controlled by changes both at transcriptional and translational level. This previously unanticipated degree of epigenetic control of myeloid cells, which affects both innate and adaptive immune responses, is likely to impact several aspects of future studies in human immunology and to inform on immunotherapeutic strategies. This Keystone Symposia meeting will cover topical aspects of basic myeloid cell biology and their interface with clinical research, bringing together scientists and clinicians working on all the subtypes of myeloid cells in health and disease, from neutrophils and monocytes to macrophages and dendritic cells. The speakers will provide an overview of myeloid cell ontogeny, role of different myeloid cell subtypes in the modulation of innate and adaptive immunity, antigen capture and presentation, mobilization from the bone marrow and trafficking during inflammatory responses. The symposium will touch on multiple areas central to contemporary immunology and cell biology, including the interface between innate and adaptive immunity, as well as the mechanisms enforcing immunosuppression in cancer and infectious diseases.

Public health relevance
It has recently been demonstrated that myeloid cells exhibit extensive phenotypic plasticity during the inflammatory response to numerous stimuli, which is modulated at both transcriptional and translational levels and affects the both innate and immune responses. This previously uncharacterized epigenetic control of myeloid cells is expected to impact directly upon multiple aspects of hematopoietic and immunological research, and to inform and influence the development of immunotherapeutic strategies. The purpose of this unique, 2013 Keystone Symposia meeting on Myeloid Cells: Regulation and Inflammation, is to bring together experts in all areas of research touching on myeloid cell biology, from experts in hematopoiesis to immunologists and cell biologists. The meeting will address multiple aspects of myeloid cells in both health and disease, from neutrophils and monocytes to macrophages and dendritic cells. The research presented at this meeting is therefore likely to significantly impact future studies in human immunology and to inform on immunotherapeutic strategies.